HUMAN CENTERED DESIGN FOR HUMAN SERVICES

The goals of this project are to explore human-centered design (HCD) implementation in the context of human services, the requirements for implementation across a range of ACF programs; and to better understand the evaluability and sustainability of HCD approaches. The project will address these goals through stakeholder and expert consultation, a review of literature and in-depth investigations, resulting in a report synthesizing the state of the field. The project will also conduct a pilot study to implement and evaluate the HCD process, and will produce a final report.